SHARE Program: Innovations in Translational Behavioral Science to Improve Self-management of HIV and Alcohol Reaching Emerging adults

SHARE P01 ABSTRACT
The purpose of the SHARE P01 research program project is to address HIV and alcohol use around three
themes; 1) Emerging adulthood (ages 18 -29); 2) Self-management of HIV and alcohol; and 3) Translational
behavioral science. Emerging adulthood is a developmental stage marked by significant change in social
roles, expectations as a new adult, and increased responsibilities. It is also marked by poor HIV self-
management and increased alcohol use. Emerging adults with HIV (hereafter called young people living with
HIV; YPLWH) may face even more challenges given intersectional stigma. This age group continues to have
very high rates of new HIV infections. Interventions designed specifically for the unique developmental
challenges of emerging adults are needed, yet emerging adults are often included with older adults in
intervention programs. The concept of self-management emerged concurrently within both the substance
abuse and chronic illness literatures, and fits well with the developmental challenges of emerging adulthood.
Self-management, a framework we have utilized in our work with YPLWH, refers to the ability to manage
symptoms, treatments, lifestyle changes, and consequences of health conditions. Current research now
identifies individual-level self-management skills such as self-control, decision-making, self-reinforcement, and
problem solving as that protect against substance use and improve other health outcomes and can be
embedded in the Information-Motivation-Behavioral Skills model. Although we have conducted multiple
studies with YPLWH, only one intervention to date (Healthy Choices conducted by our team) improved both
alcohol use and viral suppression in YPLWH in large trials. The goal of the SHARE P01 is to utilize advances
in translational behavioral science to optimize behavioral interventions and define new developmentally- and
culturally-appropriate intervention targets to improve self-management of alcohol and HIV in YPLWH. We will
focus our efforts in Florida, a state hardest hit by the HIV epidemic but with a particularly strong academic-
community partnership to support translation. We have assembled research teams to conduct self-
management studies across the translational spectrum to address self-management and improve alcohol use
and viral suppression (and thereby reduce transmission) in diverse YPLWH in Florida. The P01 will consist of
three research projects (DEFINE, ENGAGE, and SUSTAIN), representing different stages on the translational
spectrum and targeting different core competencies, supported by two cores (Community Engagement Core
and Data Science Core). If successful, the SHARE P01 has the potential to greatly advance programs
promoting self-management of HIV and alcohol use among a particularly vulnerable, but under-researched
group, emerging adults living with HIV. SHARE also has a high potential for scale-up and implementation
beyond Florida and across the United States.

Public health relevance
SHARE P01 NARRATIVE The SHARE program will develop, test and implement behavioral interventions to improve alcohol use and viral load in youth living with HIV in Florida. At the foundation is a a community engagement core in a state-wide diversity initiative to maximize public health impact.